Determining how the natural hair bundle stimulations shapes the hair cell receptor current

Abstract: Auditory and vestibular sensory cells use the hair bundle, a stair-cased array of actin-filled
stereocilia, to translate hair bundle motion into an electrical signal. Mechanically gated (MET) ion channels are
activated by force created by the pulling of a tip link that extends between stereocilia. Coordinated stimulation of
tip links regulates multiple channel openings to generate a receptor current. Mammalian cochlear hair bundles
unexpectedly were found to have weak interstereocilia connections which sensitize them to the stimulus mode.
The cochlea machine is designed to stimulate hair bundles in a manner that maximizes their sensitivity and
frequency selectivity, understanding how hair bundles are stimulated is critical to our understanding of cochlear
mechanics. We seek to understand how the mechano-electrical and electromechanical feedback between the
hair bundle, its environment and outer hair cell electromotility regulate sensitivity and selectivity of the cochlear
output. A first step in unraveling these interactions is to understand and document how hair bundles move in situ
and how this motion shapes the receptor current. This proposal bridges from the system level cochlear
mechanics to how hair bundle motion shapes the receptor current. We are uniquely positioned to investigate
these questions because we have developed the technology and created collaborations to image hair bundles
(even stereocilia in inner hair cells), tectorial membrane (TM) and reticular lamina (RL), in situ and in vitro. We
are coupling the high spatial resolution of imaging XY with optical coherence tomography which has high
vibrational resolution in Z but poor spatial resolution and with low coherence interferometry that has better spatial
resolution and excellent vibrational sensitivity. Together these tools provide a powerful platform in which to
validate our in vitro preparation and to investigate cochlea vibrational patterns, providing the first measurements
of mature hair bundle motion in situ. We will leverage this data to investigate MET receptor currents in vitro to
directly assess hair bundle filtering properties. This proposal will address three important topics: How are hair
bundles stimulated in situ (SA1)? Which hair bundle components most impact in situ motion (SA2)? How are
receptor currents modified by natural hair bundle stimulation (SA3). Specific Aim 1 measures motion in situ from
mice aged P10-15 and P24-35. These data, assisted by physics-based models of motion will determine the
mode of hair bundle stimulation and how hair bundle motion relates to TM and RL motion. SA2 probes a set of
genetically altered mice, to identify the hair bundle and TM components driving the hair bundle response. SA3
develops stimulus technology to mimic in situ stereocilia motion for IHC and OHC bundles in vitro to assess
receptor current properties under physiological conditions using physiologically relevant modes of stimulation.
These data provide insight into cochlear mechanics and into how hair bundles are specialized to best respond
to their mode of stimulation. The hair bundle is the site of many genetic disorders and the target of noise and
age-related hearing loss. This proposal provides foundational data needed for developing treatment strategies.

Public health relevance
Narrative: The hair bundle is the mechanosensitive organelle of the hair cell; how the hair bundle is stimulated dictates the receptor current properties that ultimately determine the sensitivity and frequency selectivity of the system. This proposal will determine how hair bundles are stimulated in situ, the parameters most relevant to that motion and how this stimulation impacts the hair cell receptor current. Given that both genetic and environmental insults target the hair bundle and its interface, resulting in hearing loss, quantifying these relationships is critical to our basic understanding of signal processing within the cochlea and as a first step toward developing preventative and restorative care.